Mechanistic Investigation of a Rotavirus Auxiliary Protein NSP6 Countering Host Defense

Project Summary
Rotaviruses (RVs) are the leading infectious agent of severe gastroenteritis in infants and young children.
RVs encode a small non-structural protein 6 (NSP6) with no known function. Studying NSP6 function is
difficult as it is expressed as a frameshifted product from a double-stranded RNA gene segment that also
encodes another RV protein NSP5 and the two open reading frames completely overlap. To overcome these
hurdles, we developed a robust RV reverse genetics system and generated a recombinant NSP6-deletion RV
with all possible NSP6 start codons removed without affecting NSP5 expression. For the first time, we have the
opportunity to examine the physiological role of NSP6 in RV replication, pathogenesis, and immunity in
organoid cultures and in vivo.
In preliminary studies, we found that in neonatal mice, oral inoculation of an NSP6-deletion RV resulted in
significantly lower intestinal replication and fewer diarrhea incidences than the parental virus starting at 6 days
post infection. Single-cell RNA-sequencing, further validated by multi-color flow cytometry, revealed that NSP6
expression correlated with reduced T cell numbers at the site of RV infection. NSP6 was secreted from RV-
infected intestinal epithelial cells and blocked chemotactic migration of T cells in a transwell assay. Our long-
term goal is to delineate a novel immune evasion role of RV NSP6 and use the knowledge towards
preventing and treating RV infection.
In aim 1, we hypothesize that a predicted four-α-helix structure of NSP6 is critical for its immunoinhibitory
activities. We aim to: (1) define the key amino acids within NSP6 responsible for secretion and chemoattractant
binding; and (2) identify how NSP6 sequence variation between human and animal RV strains regulates
virulence and zoonotic infection. We expect that critical mutations in α-helices will disrupt secretion and that
truncated NSP6 proteins from porcine and attenuated human RV strains cannot functionally replace the full-
length murine RV NSP6 protein in vivo. In aim 2, we hypothesize that RV NSP6 is a novel virulence factor
that acts as a molecular mimicry of chemokine receptors and inhibits T cell recruitment. We aim to: (1)
characterize the effect of NSP6 on systemic and local intestinal CD4+ and CD8+ T cell responses; (2) identify
the migratory patterns of T cells towards RV-infected epithelial cells by two-photon microscopy; and (3)
determine the immunogenicity and protective efficacy of an NSP6-deletion RV as a vaccine candidate. We
expect that NSP6 is secreted basolaterally from infected intestinal epithelial cells and suppresses T cell
chemotaxis. We also expect that immunization with an NSP6-deficient RV will induce cross-reactive T cell
responses and confer heterotypic immunity against subsequent challenges. By interrogating RV NSP6-T cell
interactions, we will gain new information that aids in development of improved live-attenuated RV vaccines
and design of novel therapeutics that dampen undesired T cell-mediated inflammation in the intestine.

Public health relevance
Project Narrative Rotaviruses are the most important causes of severe gastroenteritis, diarrhea, and death in infants and young children. We propose to elucidate the novel functions of an elusive rotavirus-encoded non-structural protein in disabling the host antiviral defense at mucosal surfaces. Our results will identify new mechanisms of viral pathogenesis and will facilitate the rational design of improved vaccines, thereby restricting rotavirus infections and reducing the overall morbidity and mortality.